ANALYSIS OF X-LINKED AUTOSOMAL DOMINANT CHARCOT-MARIE-TOOTH DISEASE

Given Charcot-Marie-Tooth disease occurring secondary to different mutations, the two disorders should be distinguishable by careful phenotypic analysis.